CORE--ASSESSMENT

The overall goal of this core is to ensure that the phenotypic information from each of the components is collected, organized, and stored in a way that facilitates direct comparisons across components and combined analyses among components. Specifically the core will serve each component by providing the training, archiving, and coordination across components of assessments and data management procedure. Functions will include: facilitating the recruitment of subjects across components; training staff in recruitment procedures and disseminating information about successful procedures; standardization of assessment procedures used in the individual components, permitting comparison of data across studies; maintaining a library of references on each assessment instrument, training videotapes and manuals, and "calibrated" trainers for the assessment interviews; documentation of any differences in instruments used in the various components; training to avoid "drift" in interview procedures; standardizing procedures for immediate checking for incorrect skip-outs, missed questions, out-of-range answers; maintaining contact with major instrument developers for updates on the instruments; archiving procedures used by our investigators for tracking of subjects, and disseminating information about successful procedures; coordinating data entry procedures to ensure that all projects are reliable procedures of entry and checking and, when an instrument is used in several components, standardizing the entry procedures; maintaining a central archive of our annual progress of data collection; documentation of procedures for handling data (including hardware, software, and backup methods) to facilitate exchange across the components.